Zebrafish Inner Ear Regeneration

PROJECT SUMMARY
Mechanosensory hair cell loss in the inner ear is a leading cause of hearing and balance disorders.
Unfortunately hair cell loss is permanent as humans have little or no capacity for regenerative recovery of hair
cells. Although there has been recent progress in the restoration of hair cells in mammals by promoting
expression of genes and pathways used during development, functional restoration is largely incomplete and
within a limited window of postnatal development. By contrast non-mammalian species from fish to birds
readily replace hair cells from surrounding supporting cell precursors. Critical to understanding hair cell
regeneration is the identification of the subpopulations of supporting cells that sustain regeneration. The
zebrafish is well established as a system to study regeneration with the advantages of advanced genetics and
in vivo imaging of living animals. Considerable progress has been made on understanding regeneration in the
lateral line system, the series of mechanosensory hair cells on the surface of the body used detect water flow
that share many properties with hair cells of the inner ear. By contrast there have been very few studies of hair
cell regeneration in the zebrafish inner ear, mainly because there has been no reliable method for causing
rapid and reproducible damage. In addition little is known about supporting cell types in the zebrafish inner
ear. Overcoming both of these obstacles would establish the zebrafish inner ear as a new model for hair cell
regeneration. We propose to develop tools for rapid, reproducible damage and regeneration in the zebrafish
inner ear. We also propose to identify inner ear supporting cell types, including potential hair cell precursors.
Successful completion of these aims will provide important tools for the community to begin new studies in
zebrafish inner ear regeneration.

Public health relevance
PROJECT NARRATIVE Loss of sensory hair cells in the inner ear results in hearing and balance disorders, and is currently irreversible in humans, but occurs in other species including zebrafish. We propose experiments to develop tools to study hair cell regeneration in the zebrafish inner ear. Successful completion of proposed work would establish this system as a new model for genetic and molecular analysis of hair cell regeneration.